B cell engineering and clinical core

ABSTRACT
The B Cell Engineering and Clinical Core aims to develop autologous human B cell engineering for sustained
antibody expression to address the limited persistence of broadly neutralizing antibodies (bnAbs) against HIV.
These bnAbs can suppress viremia in persons with HIV (PWH) off antiretroviral therapy (ART), but their short
mean elimination half-lives allow for viral rebound and resistance development. We will collect and engineer
tissues from mice, non-human primates (NHPs), and PWH. This core will provide essential biological samples
and characterization for the proposed scientific projects, facilitating the development of engineered B cells to
enhance bnAb efficacy and longevity.
The core’s specific aims are: 1. Provide primary samples from PWH and characterize sensitivity to bnAbs and
viral isolates. 2. Optimize IgH-reprogramming in NHP B cells. 3. Provide mouse, NHP, and human IgH-
reprogrammed B cells. 4. Conduct preliminary characterization of human IgH-reprogrammed B cells.
Human tissues will be supplied to Project 4 for organoid models, mice tissues to Project 2 using the B6 mouse
model, and NHP tissues to Project 3. Mouse and NHP tissues will also be provided to Project 4. Human work
will leverage samples and clinical data from ‘The Last Gift’ cohort, consisting of altruistic PWH on ART with
terminal illnesses who donate their bodies. For mouse and NHP work, we will collaborate with Tabby
Therapeutics, which specializes in innovative B cell engineering therapies, including for HIV. Their
comprehensive approach involves meticulous IgH-reprogramming of B cells across species, ensuring efficacy,
safety, and translational potential.
These resources will generate key data for the proposed projects, advancing the development of sustained HIV
remission therapies by enhancing bnAb persistence and addressing resistance challenges.